Attracting Talented and Diverse Students to Biomedical Informatics and Data Science Careers Through Short-Term Study at OHSU

Project Summary/Abstract
The main goal of the Oregon Health & Science University Biomedical Informatics and
Data Science College Undergraduate Summer Internship Program is to provide a
rich, full-time experience to students to graduate study and careers in biomedical
informatics and data science. In addition, the program aims to motivate students to
pursue doctoral training in biomedical informatics and data science that leads to
research careers in academia, government, healthcare, and industry. The funding from
this R25 grant will be used to support summer experiences for students with
backgrounds that have been historically underrepresented in biomedical informatics and
data science. With assistance and coordination from Portland State University, we will
support nine students per summer in an experience that includes:
· Knowledge of the motivations, activities, and challenges for the biomedical
informatics and data science field
· Skills development in data science through the use of data sets and standard
tools
· Participation in a faculty-led research project
· A student-led and faculty-facilitated health data ethics and equity seminar
· Scientific, career, and near-peer mentoring

Public health relevance
Project Narrative The main goal of the Oregon Health & Science University Biomedical Informatics and Data Science College Undergraduate Summer Internship Program is to provide a rich, full-time experience to students to graduate study and careers in biomedical informatics and data science. The funding from this R25 grant will be used to support summer experiences for students with backgrounds that are underrepresented in biomedical informatics and data science. With assistance and coordination from Portland State University, we will support nine students per summer in an experience that includes knowledge and skills development, participation in a research project, a health data ethics and equity seminar, and scientific and career mentoring.